Regulation and Physiological Roles of Translational Fidelity

PROJECT SUMMARY
Accurate translation of the genetic information from messenger RNA to protein depends on multiple quality
control mechanisms, which collectively maintain the average levels of translational errors at 10-4 for amino acid
misincorporation (missense errors) and 10-2 for stop codon readthrough. However, increasing evidence shows
that such translational fidelity is not fixed, but is rather affected by various environmental cues and genetic factors.
Currently, we are only beginning to understand the regulatory networks leading to the fluctuation of translational
fidelity during environmental changes and the resulting physiological responses. Translational errors can lead to
reduced fitness, such as growth defects in bacteria and neurodegeneration in mammals, but may also benefit
cells under certain stress conditions. Recently, we have shown that translational error rates vary from cell to cell
in a genetically-identical bacterial population, raising the interesting question as to how fluctuation of translational
errors affects the behavior of individual cells. In my laboratory, we are interested in developing and applying new
technologies to understand the regulation and physiological roles of translational fidelity at both the population
and single-cell levels. We are using our recently developed high-throughput reporter system to screen for
conditions that alter translational fidelity, and have already identified novel environmental and genetic factors
that are critical for this process. Next, we will determine the underlying mechanisms and expand our screens.
Another research direction is to study how translational fidelity affects bacteria-host interactions, which is poorly
understood. Our recent work reveals that either decreasing or increasing translational fidelity impairs expression
of virulence genes and motility in Salmonella, suggesting that an optimal level of translational errors benefit
bacteria during host interactions. We will further determine the regulatory networks using population and single-
cell approaches. These studies will provide important insights into the roles of translational fidelity in
environmental adaption and the regulatory mechanisms.

Public health relevance
PROJECT NARRATIVE Protein synthesis is a major pathway targeted by antibiotics, and the rise of multi-drug resistant bacteria calls for further understanding of the translational machinery to improve current antimicrobial treatment. Escherichia coli and Salmonella enterica cause over a million illnesses and tens of thousands of hospitalizations annually in the United States alone. Our work will provide insights into adaptation of such bacterial pathogens during stress conditions and facilitate development of novel antimicrobial strategies.